Pathological Mechanisms of Human Cerebellar Malformations

PROJECT SUMMARY
While the cerebellum's role in motor function is well recognized, the cerebellum also plays cardinal roles in
affective regulation, cognitive processing, and linguistic function (1). Indeed, there is a growing recognition that
disruptions of cerebellar development cause considerable cognitive, behavioral, and social deficits (2-6). Yet,
though cerebellar malformations are amongst the most commonly recognized structural brain malformation in
prenatal imaging (7-10). Reliable information about their cause is sparse (11, 12). Diagnosis is based on
imaging studies which are often unreliable, a problem amplified during fetal development (13, 14). In stark
contrast to the wealth of knowledge gained over the decades regarding the mechanisms and genes driving
cerebellar development in mice and other model organisms (15-19), we actually know very little about human
cerebellar development. We recently reported multiple aspects of human cerebellar development significantly
differing from mice and even rhesus macaque, a non-human primate. These discoveries challenge our current
mouse-centric models of normal cerebellar development and the pathogenesis human cerebellar
developmental disorders (20). This proposal seeks to advance knowledge of normal developing human
cerebellum and cerebellar birth defects, leveraging 1) our unique access to normal and abnormal human fetal
cerebellar tissue and 2) our extensive, specific expertise of mouse and human cerebellar development and our
deep knowledge of human cerebellar malformations. Our detailed characterization of normal and abnormal
cerebellar development, combined with humanized mouse models will improve our understanding of the
biology of normal human cerebellar development and the pathogenesis of a clinically important human
cerebellar birth defect, Dandy-Walker malformation (DWM). They will provide gold standard histological and
transcriptomic datasets to assess model systems of human cerebellar development, generate the first
“humanized” mouse models of human cerebellar development and finally, enable improved and sorely needed
prenatal diagnostic information for families affected by cerebellar malformations.

Public health relevance
PROJECT NARRATIVE Human cerebellar malformations are clinically important birth defects that cause substantial morbidity and mortality and are poorly understood. Cerebellar involvement is also central to common neurodevelopmental disorders, including Autism and Intellectual Disability, yet very little is known about human cerebellar development. These experiments are designed to fill a considerable knowledge gap regarding the cellular and molecular programs that drive normal human cerebellar development and the pathogenesis of human cerebellar malformations.